Engaging new cognitive and motor signals to improve communication prostheses

PROJECT SUMMARY
Communication technology for people with severe speech and motor impairments (SSMI) continues to
improve, with recent advances being made in the neural control of communication devices. In prior NIDCD-
supported research, our research team developed high-performance intracortical brain-computer interfaces
(BCIs) to enable point-and-click control of computer cursors and virtual hands via brain activity alone. Despite
these advancements, typing interfaces remain limited in communication speed (8 words per minute) due to the
inherent slowness of selecting keys one by one with a pointing device. Recently, we set a new communication
record with a speech BCI that decoded neural activity evoked by attempted speech into text (62 words per
minute). Speech BCIs currently show the most promise for achieving the long-standing goal of restoring fluent
communication at conversational speeds to people with SSMI. However, speech BCIs still require further
improvements in performance to allow for more widespread adoption. The goals of this project are to improve
speech BCI performance using new methods and brain signals in 3 ways: (1) reduce the calibration burden on
the user by translating self-recalibrating algorithms we have demonstrated in handwriting to the decoding of
speech, (2) improve ease-of-use and speed by leveraging signals related to inner speech (as opposed to
motor signals related to attempted speech, which can be slow and difficult for people with SSMI), and (3)
improve accuracy by leveraging complementary signals from Broca's area that represent abstract linguistic
features of the user's intended message, as opposed to the articulator movements that make it up. Upon
completion, this project will advance both the capabilities of speech BCIs for communication and our
understanding of the function of speech-related areas of the brain.

Public health relevance
PROJECT NARRATIVE People with brainstem stroke, advanced amyotrophic lateral sclerosis (ALS, also known as Lou Gehrig’s disease), or other disorders can become unable to speak despite being awake and alert. In this project, we seek to improve the performance of speech brain-computer interfaces using newly discovered brain signals and improved decoding methods, with the goal of allowing people with severe speech and motor impairment to once again engage in natural, rapid speech-based communication with colleagues, loved ones and health care providers.